CLINICAL TRIAL OF OLSALAZINE IN ANKYLOSING SPONDYLITIS

To establish tolerability and efficacy of olsalazine in patients with ankylosing spondylitis unassociated with overt inflammatory bowel disease.